FUNCTIONAL APPROACH TO AVERSIVELY MOTIVATED BEHAVIOR

This proposal is designed to see if a functional approach can improve understanding of aversively motivated behavior. The research tests the hypothesis that if there is a risk of predation, when an animal is foraging and/or consuming food, the animal will modify its activity patterns in such a way as to reduce that risk. A model of aversive motivation is described that predicts that the presence of aversive stimulation will not simply suppress appetitively motivated behavior (as two-process theory predicts) but rather it should cause appetitively motivated behavior to become "reorganized". The proposed experiments will examine the effects of increasing the probability of aversive electric shock on meal patterning. Rats will live (i.e. spend 24-h a day for many months) in a modified operant chamber. Foraging and consumption of food will be modeled by having food made available on chained FR:CRF reinforcement schedules. A number of dependent variables related to meal patterning and energy balance will be examined. Preliminary results obtained so far show that rats decrease meal frequency when shock probability is increased. However, net caloric intake and body weight are defended by compensatory increases in meal size. This behavior is successful at reducing the time the rat is exposed to the risk of shock without compromising energy balance.